Small molecule agonists of the relaxin 1 receptor

The NCATS Early Translation Branch (ETB) hosts a broad and comprehensive program for the discovery of drug candidates directed towards rare diseases and pharmacological tools to probe the function of the human genome. ETB conducts research to understand the underlying principles driving the translation of basic research discoveries into tangible improvements in human health.

During this period, the collaborative team has worked to characterize the lead molecules using in vitro assays and in vivo models. In vivo pharmacokinetics and efficacy data were obtained for several molecules, identifying metabolically stable analogues displaying good pharmacokinetics. Formulation studies are also underway. Development of several functional assays is ongoing to aid in the identification of a strong preclinical candidate.